PROJECT MANAGEMENT SUPPORT FOR COMMUNITY ENGAGEMENT ON TRANS-NIH THERAPEUTICS AND VACCINE TRIALS

Project Management support in setting up community engagement programs focused on populations most impacted by COVID-19 for Trans-NIH therapeutics and vaccine trials.